Mechanotransduction via LIM Domain Protein Mechanosensing

Project Summary
Mechanical interactions play a fundamental role in physiology, allowing cells to move, generate forces, and
assemble into multicellular structures. Key to these processes is the ability of cells to turn mechanical signals
into biochemical signals, an activity known as mechanotransduction. The search for mechanosensitive proteins
that could facilitate mechanotransduction has primarily focused on proteins that undergo conformational
changes in response to force or proteins that display changes in the bond kinetics under load. There exists
another class of proteins, however, that recognize structures under strain.
The canonical example of this class of proteins is the LIM domain protein zyxin, which recognizes strained
actin stress fibers and recruits actin polymerization factors to repair them. Recent work has highlighted that the
strain sensing mechanism of the LIM domains is not unique to zyxin and that numerous other members of the
family of LIM domain proteins display a similar ability. This suggests LIM domain proteins could act as
mechanotransducers, recognizing strain via their LIM domains and converting it to other biochemical signals
via interactions with the other domains in the protein. To explore this hypothesis further it is crucial that we
understand how LIM domains recognize strained actin filaments, and how those interactions propagate signals
downstream of the strain sites.
Here we propose to establish rigorous experimental strategies to decipher the mechanisms underlying LIM
domain protein mechanotransduction. We employ a combination of biophysical techniques including laser
ablations, optogenetics and cell stretching to quantitatively and repeatedly induce strain sites in the actin
cytoskeleton. In Aim 1 we will test alternative mechanisms of LIM domain strain sensing by comparing proteins
from the testin family of LIM domain proteins which require only a single LIM domain to recognize strain sites,
compared to the three tandem LIM domains that zyxin requires. In Aim 2 we will test whether in addition to
stretched actin filaments in stress fibers, LIM domain proteins can recognize other strained actin structures,
such as compressed stress fibers or actin meshworks. Finally, in Aim 3 we will investigate how binding of LIM
domain proteins to strain sites leads to a propagation of that mechanical signal to other parts of the stress fiber
and the extracellular matrix. Together these studies will greatly expand our knowledge of mechanotransduction
and provide insight into this fundamental signaling mechanism.

Public health relevance
Project Narrative Mechanical interactions and signals provide the basis for numerous physiological processes including allowing cells to move and form multicellular structures. Misregulation of these mechanical signals has been implicated in a broad array of diseases and developmental impairments. This project investigates novel mechanisms for how proteins can sense these mechanical signals and convert them to biochemical signals, thereby uncovering new signaling pathways and potentially identifying new therapeutic targets.